HUMAN INSULIN ANALOGUE X14 ®ULAR HUMAN INSULIN AS MEAL RELATED INSULIN

Multicenter open-label asymmetrically randomized (1:1,X14 to Regular Human Insulin) trial with two parallel active treatment groups. An open-label tria has been chosen because Regular, Human Insulin is recommended to be injuected 30 minutes before meals while X14 is to be injected immediatley before meals. Blinding the study (double dummy) would mean an unacceptable number of injuctions per subjects per day. A fixed four week run-in period will ensure that all subjects are on a multiple injection treatment regimen with Regular, Human Insulin as meal related insulin and NPH, Human Insulin ad basal insulin and trained in trial related procedures prior to randomiziation.